MTG: Math Team Games

Project Summary
The overall objective of this Phase II research and development work is to commercialize of a new software
product called MATH TEAM GAMES (MTG). MTG is being developed to enable the playing of collaborative
math games on mobile tablet and touchscreen devices by students of high school algebra in rapidly emerging
one-to-one (1:1) e-learning environments. In e-learning, 1:1 refers to both teachers and students using
networked mobile devices in either a traditional classroom where they are co-located or in a virtual classroom
where they are not (distance learning). In this proposal, the term “tablet” refers to any device with a
touchscreen where users write directly on the screen with a stylus or fingertip. Fluidity’s goal is to build MTG
using recently patented novel features designed specifically to broaden the use of their award winning product,
FluidMath, currently being used in traditional classrooms. Fluidity’s recently patented and patent pending
technology transforms the GUIs of networked tablets into a common work page (a virtual whiteboard) on which
students can collaborate using handwritten math notation to play math games. Teachers monitor student
performance on a teacher’s tablet connected in the network. Unlike any other game application, MTG
understands math input and enables participants to enter and collaboratively modify handwritten math notation
and/or hand drawn sketches on its common work page.
Currently, there are no team games which can be played on networked tablets that provide an intelligent
shared workspace for handwritten math input. MTG solves this problem and optimizes the significant
investment in tablet computers that is being made by educators for use in 1:1 e-learning environments. MTG
provides first-of-a-kind collaboration functionalities for use on a common intelligent workspace upon which
participants can interactively collaborate playing games using handwritten math notation and wherein teachers
can teach, observe, and evaluate their students’ collaborative problem solving (CPS) skills.

Public health relevance
Project Narrative The research conducted in this project will help to develop effective technologies for learning math and will provide a foundation for improving the STEM learning process ultimately benefiting not only those who have an aptitude for math but also for those who struggle to understand its basic principles.